Identification and Characterization of Cell-Specific Transposable Elements Implicated on Alzheimer Disease and Healthy Aging

Abstract
Alzheimer disease (AD) is the most common form of dementia and neurodegeneration affecting more than 5
million Americans with no current effective treatment. Several Mendelian mutations and risk variants have
been identified. We and others have shown that AD is associated with changes in brain cell proportion and
transcriptomic changes, some of them are also cell specific. Additionally, the latest genetic studies implicate
cell-specific pathogenic events that lead to disease. Pathogenic variants in APP, PSEN1 and PSEN2 affects
APP processing leading to Aβ aggregates and neuronal death. Genetic variants in TREM2 and MS4A modify
AD risk by affecting microglia activity. To fully understand and characterize the role of transposable elements
(TE) in AD pathogenesis there is a need to novel and multidisciplinary approaches. Here we will combine novel
genomic approaches in human brain tissues, direct converted neurons and iPSC-derived microglia (iMGL) to
identify cell-specific TE and downstream (chromatin accessibility, transcription) changes implicated in AD. We
will leverage a large and unique resources of human brain samples and fibroblast from individuals with
mutations in APP, PSEN1, PSEN2, as well as risk variants in TREM2, MS4A or APOE. We will also use the
direct converted neurons and iMGL, together with new genomic editing approaches to target and characterize
the mechanism by which TE contribute to disease.

Public health relevance
Narrative Transposable elements have been implicated in neurodegeration, including Alzheimer disease (AD). Recent genetic studies have highlighted the role of not only neurons but also microglia in the pathogenesis of AD. Therefore, to fully understand the biology of the disease there is a need to perform depth molecular characterization in a cell-specific manner. The overall goal of this proposal is to identify and characterize neuronal and microglia-specific TE and downstream (chromatin accessibility, transcript levels and new transcript) changes implicated on disease. Functional characterization of TE implicated in disease will also be instrumental to identify potential therapeutical targets.